North Carolina Diabetes Research Center

PROJECT SUMMARY/ABSTRACT – CENTER OVERVIEW
This proposal seeks to create and support an interactive regional diabetes research community (184 members)
across four premiere research institutions in North Carolina, who currently garner over $70 million annually for
support of their diabetes research: Duke University (Duke) The University of North Carolina at Chapel Hill (UNC),
Wake Forest School of Medicine (WF), and North Carolina A&T (NC A&T). The North Carolina Diabetes
Research Center (NCDRC) will support Research Cores that represent unique strengths at each institution.
These Cores will support studies of the current Research Base at each respective institution, but will also be
made available to the other NCDRC institutions, where their use has been hampered by less easy access. An
expanded Pilot and Feasibility Program will encourage use of these now regional Cores, bring to the field new
investigators and young scientists, and draw those not previously working in the field. We will leverage the
existing infrastructure at each institution’s NIH Clinical and Translational Science Award (CTSA) site, to guide
investigators to other resources that enhance their scientific productivity and efficiency. The goal of this new
Center is to create connectivity in the diabetes research community, thereby fostering new advances in basic
and translational diabetes research. We will take advantage of the substantial pre-existing resources and
capabilities at each institution, and connect investigators to resources unique to each campus, to maximize the
ability of member investigators – whether new investigators or scientists new to diabetes research – to answer
important questions across the spectrum of translational approaches. There is a history of collaboration in
diabetes research among the four institutions. Most importantly for this application, however, are the unique
strengths that can be shared among our campuses, and the enormous potential for a large and cohesive
community of investigators to advance diabetes research further. Regional Core Resources to be directly
supported by the NCDRC will include a Genomics and Proteomics Core, and a world-renowned Metabolomics
Core, including not only a range of state-of-the-art analyses but equally importantly, interpretive services that
are often a bottleneck for such resources. Expertise in the Advanced Clinical Sciences Methods Core will be
focused on driving translation of discovery to clinical care of diabetes, emphasizing state-of-the-art methods.
Each Core will offer specialized Research Navigators to guide diabetes-focused investigators. Finally, an
Enrichment Program will plan and sponsor an annual symposium, reaching out to investigators whose work and
techniques could inform diabetes research. Fellows supported on T32 or T35 training programs at Duke, UNC,
and WF, whose work is evolving in a diabetes-relevant direction, will be a special focus for outreach.

Public health relevance
PROJECT NARRATIVE - CENTER OVERVIEW The Proposed North Carolina Diabetes Research Center (NCDRC) seeks to foster diabetes-related research among investigators – whether established, early-career, or new to the field – at and among 4 premier research institutions in the state (Duke, University of NC at Chapel Hill, NC A&T, and Wake Forest). The Pilot and Feasibility Core will provide funding for the most promising ideas among NCDRC scientists; the Core services will provide access to unique resources and expertise among all 4 campuses, and their cadre of Research Navigators will enable the studies’ efficient completion; and the Enrichment Program will plan and sponsor an annual symposium, to which NIH-supported trainees and investigators whose work could inform the future of diabetes research will be especially invited.